Mechanisms of ketosis and near-normoglycemia remission in obese African Americans with ketosis-prone diabetes

Project Summary/Abstract
It is estimated that ketosis-prone diabetes mellitus (KPDM) affects 20-50% of African American patients with
newly diagnosed diabetes who present with diabetic ketoacidosis (DKA). At presentation of DKA, these
patients have a severe decompensation in insulin secretion accompanied by severe insulin resistance. Unlike
patients with type 1 diabetes, following intensive insulin treatment, many of these patients exhibit
improvements in insulin secretion and insulin sensitivity and are able to discontinue insulin therapy (near-
normoglycemia remission, HbA1c < 7%, fasting glucose < 130 mg/dl while off insulin for at least one week).
The period of near-normoglycemia remission is variable and many patients eventually experience a
hyperglycemic relapse or even DKA while some stay in remission due to sustained insulin secretion. Despite
the phenotype being recognized for many years, the underlying mechanisms leading to ketosis and
maintenance of beta-cell function are unknown. Further, increased intra-organ (pancreas and liver) fat can also
play a role in remission. High resolution metabolomics and magnetic resonance imaging offer a comprehensive
way to assess multiple pathways and imaging characteristics. This proposal will leverage already collected
samples and participants from the PI’s K23 proposal to examine pathways leading to ketosis and sustained
remission. Aim 1 will compare metabolomic signatures between people with DKA and hyperglycemia without
ketosis. Aim 2 will compare metabolomic signatures at time of insulin discontinuation and their relationship with
sustained beta-cell function. Aim 3 will explore whether differences in pancreatic and hepatic fat associate with
sustained remission and beta-cell function. The Aims, together with new collaborators with complementary
expertise will generate data to explore novel hypotheses for new independent proposals by the PI.

Public health relevance
Project Narrative Ketosis-prone diabetes mellitus (KPDM) is subtype of diabetes that affects 50% of African Americans presenting with diabetic ketoacidosis (DKA) and characterized by loss of insulin secretion and action, which recover after intensive insulin treatment. However, studies are lacking on the underlying mechanisms leading to ketoacidosis and recovery of insulin secretion. This study will help close this important knowledge gap by using novel methodologies to explore hypotheses that explain the clinical course of KPDM which will ultimately yield evidence-based interventions to prevent ketoacidosis and sustain improvements in insulin secretion.